Hormonal Influences on Inflammation in Endometriosis

It is estimated that around 10% of reproductive-age women of European ancestry, and 15% of women of Asian ancestry are impacted by endometriosis. In endometriosis, glandular epithelium and stroma closely resembling the cells of the endometrium grow outside of the uterine cavity, evading the typical cell-intrinsic (programmed cell death) and cell-extrinsic safeguards (such as immune surveillance) that should prevent cells from surviving at ectopic locations. Endometriosis causes myriad symptoms including infertility, dysmenorrhea (menstrual cramps), deep dyspareunia (pain with deep penetration during sexual activity), dyschezia and dysuria (painful bowel movements and voiding), and chronic pelvic pain. Epidemiologic and genetic studies consistently find associations between endometriosis and inflammatory conditions such as asthma, irritable bowel syndrome and autoimmune disorders. Inflammation plays a central role in endometriosis, and the overarching hypothesis of this research is that studying risk loci shared by endometriosis and inflammatory conditions likely have a role for hormonal modulation, since endometriosis is an estrogen-driven disease.
The goal of this proposal is to characterize key immune pathways that interact with hormonal responses in endometriosis. This will be achieved through large-scale population based genetic comorbidity studies and single cell systems biology methods to nominate shared risk genes and state-of-the-art single cell and spatial molecular profiling of follicular and luteal phase endometriosis. Key cell-cell signaling axes will be validated for their therapeutic potential using heterotypic in vitro and in vivo models of endometriosis. We will primarily focus on the proinflammatory IL1 pathway as a risk locus for endometriosis coincides with the IL1 gene family cluster. Based on integration of genome-wide risk data and single cell gene expression analysis of endometriosis we hypothesize that IL1A and/or IL1B expression by M2 macrophages combined with IL1 receptor expression in hormone-sensitive endometriosis epithelial cells is the pathway underlying risk at this locus. We will validate this hypothesis with multiomics and spatial profiling, and then dissect the roles of the key genes and cell populations using our existing state-of-the-art in vitro and in vivo models.
This research will validate IL1 signaling as a key therapeutic target for endometriosis-associated inflammation, and will likely nominate additional candidates. Subsequent research will focus on clinical translation of these results. Endometriosis represents the ideal system to study hormonal regulation of inflammation, and pleiotropy, and so we expect that the impact of this study will extend to other inflammatory traits that are more common in women, and to the post-GWAS field in general.

Public health relevance
Endometriosis is remarkably common but poorly understood. Through this project we aim to better understand the relationships between reproductive hormones and inflammation in endometriosis. We expect this insight to lead to novel ways to manage inflammation and inflammation-associated pain in chronic conditions.